WELFARE REFORM AND THE PERINATAL HEALTH OF IMMIGRANTS

This is a prospective cohort study of childbearing Latina women in San Francisco to determine whether welfare reform is associated with changes in utilization of prenatal care, utilization of infant health services, or infant immunization status. The investigator will recruit a large cohort of women at SFGH and conduct two study visits to analyze the relationship between welfare reform policies and perinatal and infant health outcomes. The GCRC will be used as an interview facility to conduct private interviews with study participants.